Dissecting the role of cortico-basal ganglia circuit diversity in action learning from reinforcement

Project Summary/Abstract
To learn novel actions through reinforcement, a fundamental mechanism of motor learning, the brain needs to
causally link previously performed movements to their resulting outcomes. But even single limb movements
consist of multiple aspects, which poses what is known as the credit assignment problem: ‘What was it that I just
did that led to the desired outcome?’ Through repeated reselection of the movement the brain converges on
which aspects are relevant, and variability is reduced in those aspects, refining the action into a skill.
Current theories suggest that this process is implemented in the cortico-basal ganglia-thalamo-cortical loop.
Cortical information about planned and ongoing movements is conveyed to the striatum via corticostriatal
projections. If the movement leads to a desired outcome, dopamine is released in striatum, strengthening the
activated corticostriatal synapses. This plasticity, in turn, is thought to allow the reselection of the movement
through the basal ganglia-thalamo-cortical loop. It is unclear however how different aspects of the action are
distinguished such that the relevant ones are refined. The anatomical heterogeneity of the corticostriatal
sensorimotor command may provide a circuit-level mechanism of this process. In the K99 mentored phase, I will
dissect this mechanism. I hypothesize that distinct corticostriatal projections convey different aspects of the
motor command and what is learned is determined by which projections are reinforced.
I have developed a head-fixed behavior task in which mice get rewarded for moving a joystick into a defined
circular target area. In this task, a specific movement direction, a position of the rewarded endpoint, or both may
be reinforced and learned by mice. I use behavioral measurements and manipulations, and neural decoding of
the different corticostriatal motor commands to probe what individual animals learn. I will be mentored by Dr. Rui
Costa, Dr. Daniel Wolpert, and collaborator Dr. James Murray to hone my behavior analysis skills and train in
cutting-edge methods for neural decoding, such as the use of neural networks. Then I use optogenetic
manipulation to directly test if anatomically distinct corticostriatal commands determine what animals learn.
Besides reselection of cortical motor commands through thalamus, the basal ganglia control movement by
disinhibiting brainstem motor centers, providing a parallel pathway for action refinement. One such center, the
red nucleus, is directly involved in forelimb control, as previously shown by me and others, and is also innervated
by the cerebellum. In the R00 phase, I will start my independent research by investigating if action refinement
also depends on basal ganglia control of brainstem motor centers, particularly the red nucleus. As I transition to
independence, Dr. Megan Carey will advise me in questions of cerebellum-related motor control. All mentors will
promote my career development. These research and training experiences will place me as a competitive
candidate to become a successful independent PI and give me the needed support to achieve milestones of
getting my first R01 and publishing the first independent paper from my lab.

Public health relevance
Project Narrative To learn novel skilled actions from reinforcement, the brain causally links the movements it generates to resulting outcomes, reselects these movements, and refines the relevant aspects. Such learning from reinforcement is also at play during motor recovery from central nervous system injuries such as stroke. Here I dissect the circuit- level neural implementation of this mechanism using sophisticated behavior, longitudinal neural recordings, and cell-type specific manipulations that will add unprecedented detail to theories of learning from reinforcement.